C# CODE DEVELOPMENT AND SYSTEM VALIDATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This project is focused on validating the second generation user interface and processing algorithms coded in C# through phantom measurements.